Interdisciplinary Training in Lung Physiology and Biomedical Engineering

DESCRIPTION (provided by applicant): The Department of Physiology & Biomedical Engineering (BME) at Mayo Clinic has a long and rich history of preparing pre- and postdoctoral students for academic careers in a biomedical research environment that is increasingly more technological and complex. We strongly believe that a training grant that takes the novel approach of encouraging and nurturing biomedical research skills alongside computational, mathematical and engineering skills will create a unique cadre of future leaders in biomedical research related to lung disease. diverse backgrounds, we plan to recruit: 1) Predoctoral students via the Mayo Graduate (PhD students) and Medical (MD/PhD students) Schools; 2) Postdoctoral PhD scientists from applicants working in or applying to faculty laboratories; and 3) Postdoctoral MD or MD/PhD clinician-scientists from the large pool of residents or fellows from participating clinical departments (especially Anesthesiology, Pulmonary/Critical Care, Radiology 15 NIH-funded key faculty mentors and 3 postdoctoral trainees (with PhD and/or MD). From a pool of highly competitive eligible candidates with and Surgery). A total of were selected based on their outstanding pre- and trainees 4 addition, in funding. extramural via Under the auspices of the Training Program in Lung Physiology and Biomedical Engineering we propose a multifaceted program to train the next generation of biomedical researchers in lung physiology and disease. The primary objectives of the training program will be to train three groups of trainees for biomedical research careers in lung physiology and disease: 1) Predoctoral PhD (or MD/PhD) students with undergraduate backgrounds in engineering, mathematics or physics; 2) Postdoctoral PhD scientists with backgrounds in engineering, mathematics, physics or basic biomedical sciences; and 3) Postdoctoral MD or MD/PhD clinician- scientists. To achieve our objectives, we are requesting support for 3 predoctoral students (PhD or MD/PhD) postdoctoral training records and their abilities to support associate faculty members were selected based on their considerable promise for successful independent academic careers and their dedication to mentoring the next generation of biomedical scientists in lung Physiology & BME) who has extensive experience in biomedical research and demonstrated leadership in physiology and disease. The program will be led by Dr. Gary Sieck (Professor and Chair of the Department of graduate and postgraduate education as well as administration at the departmental, institutional and national. In addition to a common formal didactic program in lung physiology and BME, individual trainee needs will be met by elective coursework. Trainees will also receive training in writing manuscripts and grant applications. Furthermore, they will be encouraged to network and become involved in the scientific community through presentations at regional, national and international meetings. Success of the training program will be determined by retention and placement of trainees in academia at all levels of career development and ultimately as established, extramurally-funded biomedical researchers.

Public health relevance
Respiratory and lung diseases such as asthma, bronchitis, COPD, pulmonary fibrosis, and pulmonary hypertension impose an enormous healthcare and financial burden on the US population as well as worldwide. There is substantial societal need to train the next generation of lung researchers to take the lead in addressing these important healthcare issues. In this regard, the collaboration between scientists and engineers is key. We strongly believe that a training grant that takes the novel approach of encouraging and nurturing biomedical research skills alongside computational, mathematical and engineering skills in carefully selected trainees will create a unique cadre of future leaders in biomedical research. Under the auspices of the Training Program in Lung Physiology and Biomedical Engineering, we propose to use a multifaceted approach to train this next generation of researchers using a cadre of outstanding basic research and clinical faculty mentors with diverse backgrounds, and a world-class research and educational environment within the Department of Physiology and Biomedical Engineering at the Mayo Clinic.